Selecting HA glycosylation for improved vaccine responses

Selecting HA glycosylation for improved vaccine responses
This application responds to PA-18-859 "Advancing Research Needed to Develop a Universal Influenza
Vaccine" and addresses the goal to “support rational design of universal influenza vaccines”.
The low Influenza A virus (IAV) vaccine effectiveness (VE) stems from the ability of the virus to evade existing
immunity. Its error-prone polymerase enables rapid evolution of the surface glycoprotein antigens hemagglutinin
(HA) and neuraminidase (NA). Significantly, among the more prevalent mutations that occur as an IAV strain
undergoes antigenic drift is the appearance of new N-glycosylation consensus sequences (sequons) on the HA
globular domain. The appearance of new glycosites shields underlying amino acid residues from antibody
contact. However, because the host receptor binding sites (RBSs) also reside in the HA head group, variations
in head group glycosylation have the simultaneous potential to harm viral fitness by interfering with virus binding
to its host receptor.
HA glycosylation is macro- and micro-heterogeneous, meaning that each HA glycosite has a distribution of
glycoforms that differ in their physicochemical and lectin-binding properties. HA therefore consists of
heterogeneous populations that differ by glycosylation, antigenicity, and immunogenicity. Unfortunately, the
glycosylated structures of HA populations most suited for vaccine use remain unknown for IAV strains. This lack
of information results in over-reliance on genomic information that cannot predict the level of glycosylation at a
given site, the compositions of the attached glycans, and which glycosylated populations of HA are most
immunogenic.
We propose to use glycoproteomics, molecular modeling, and antigenic cartography of HA glyco-populations to
develop a detailed understanding of the relationship between HA glycosylation and immunogenicity for
representative H1N1 strains.
This study will enhance our understanding of the natural history of influenza viruses. In addition, we anticipate
that this knowledge could be employed to select HA sequences for producing recombinant influenza vaccines
with enhanced immunogenicity and VE. Unlike vaccines based on attenuated or inactivated virus, recombinant
vaccines are created synthetically and can be prepared in advance of the emergence of a seasonal or pandemic
strain of virus. Knowledge of the optimal HA glycosylation pattern would provide important guidance in
recombinant vaccine design.

Public health relevance
Project narrative Influenza A virus (IAV) is one of the major causes of seasonal influenza, being responsible for an average of 36,000 deaths in the US each year. Despite the fact that variation in glycosylation is a major mechanism whereby the virus escapes immune surveillance, there has been no systematic effort to correlate site-specific IAV glycosylation with viral immunogenicity. In this proposal we will use state-of-the-art mass spectrometry, antigenic cartography, and computer modeling of glycosylated surface antigens from multiple strains of IAV to elucidate this understanding, with the expectation that it will facilitate the development of more effective vaccines.